Project 4: Measurement and Engineering Solutions to Detect and Prevent N-Nitrosamine Exposure

PROJECT SUMMARY/ABSTRACT – PROJECT 4
N-nitroso (-N-N=O) compounds include some of the most powerful chemical mutagens known and encompass
a family of chemicals with hundreds of different structures. However, only a handful of N-nitrosamines are
routinely measured via EPA Standard Methods, and these methods are not effective at the low levels anticipated
to cause health impacts. To overcome this challenge and reduce human exposure, Project 4 seeks to measure
and destroy a suite of N-nitrosamines at the point of use in homes, where they are needed most to protect public
health and the environment. First, Specific Aim 1 is to develop methods to detect a suite of established and
novel N-nitrosamines using multi-dimensional gas chromatography paired with both mass spectrometry (for
identification) and flame ionization detection (for quantification with authentic standards or via an effective carbon
number concept when authentic standards can be neither synthesized nor purchased). This technique enables
estimation of nearly a dozen critical environmental parameters, such that novel molecules detected in complex
mixtures will have at-the-ready physicochemical metrics to feed environmental fate models and predict exposure.
Water samples will be collected in collaboration with the Community Engagement Core using traditional
collection methods as well as novel Recognition-Solid Phase Extraction (R-SPEs) materials that concentrate N-
nitrosamines (to be developed in Project 3), and fractions of extracts will be provided to Project 2 for mutagenicity
assessment. Knowledge about the levels of NDMA will inform Project 1 so that environmentally relevant levels
can be studied for their biological impacts using novel genetically engineered mice that are sensitized to NDMA.
In addition, the Data Management and Analysis Core will integrate data for “what” and “how much” with data on
biological impact to inform risk. Armed with knowledge of environmental levels of N-nitrosamines, Specific Aim
2 is to develop novel in-home water filtration technologies based on electrochemical processes and
molecular recognition with enzymatic destruction. The latter relies on genetically engineered microbes that
act as non-living scaffolds for enzymes; as such, it overcomes many classical challenges faced by bioreactors
and opens up vast possibilities to leverage advances in biotechnology for long-awaited revolutions in water
treatment. Specific Aim 3 will test the degradation products to ensure that they are no longer genotoxic
by collaborating with Project 1 to use “Chem-Sense” cells that act as animate detectors of DNA damage.
Trainees will drive the research and will be supported by the Research Experience and Training Coordination
Core to ensure optimal professional development. In addition, Project 4 will benefit from activities organized by
the Administrative Core that ensure close collaborations with other Projects and with the Cores, as well as
opportunities for research translation to stakeholders, including people living near the Olin Chemical Superfund
Site and the Passamaquoddy Tribe. Via a Systems Approach of interactions and interdependencies, Project 4
will contribute to the protection of human health from hazardous substances.

Public health relevance
PROJECT NARRATIVE – PROJECT 4 N-nitrosamines are probable human carcinogens that are present not only at Superfund Sites, but also in the municipal water that use used by the Passamaquoddy Tribe, making it important for this team to develop novel technologies for detecting N-nitrosamines in the environment and in people's tap water, as well as to create novel nanotechnologies and biotechnology approaches to destroy N-nitrosamines. The proposed studies will enable 1) agencies to understand the fate of this important class of compounds in the environment, 2) identification of contaminated water, and 3) deployment of under-sink devices that will protect people from these hazardous chemicals. Technologies that will be created and results from these studies will be shared with stakeholders at the local, state, tribal, and national levels (including the Environmental Protection Agency), in order to maximize the impact of this work on public health.